Defining cerebellar computation and function during associative learning with two-photon optogenetics

Project Summary
The cerebellum plays a significant role in cognitive, emotional, and social behaviors, but we lack a basic circuit-
level understanding of how it contributes to these non-motor functions. Classical cerebellar learning models
postulate that cerebellar Purkinje neurons use error feedback to shape future actions, but recent recordings of
Purkinje activity in associative learning tasks revealed that Purkinje neurons encode sensory, cognitive, and
reward-related responses, not motor errors. These remarkable observations challenge the error-learning model
and suggest novel cerebellar functions during associative learning. However, this has never been causally
tested, and it is also unclear how these non-traditional responses are acquired during learning. This gap in
knowledge is largely due to limitations of past technologies, since linking Purkinje activities with behavior would
require simultaneous recording and perturbation of Purkinje activity, ideally with single-cell and sub-second
precision in awake behaving animals. Therefore, to define non-motor computations in the cerebellum and to
understand how they contribute to behavior, I will employ two-photon calcium imaging and holographic
stimulation of novel excitatory and inhibitory opsins to record, track, and modify Purkinje activities
throughout learning. My preliminary data suggests that complex spike responses in Purkinje neurons encode
reward-related signals, whereas simple spike responses in Purkinje neurons encode timing signals that precede
motor output. Based on this data, I hypothesize that reward-related signals present in complex spike
responses are necessary for the acquisition of timing responses in simple spikes in Purkinje neurons
and are therefore crucial for generating well-timed behaviors during associative learning. In the first Aim
(K99), I will characterize simple and complex responses within individual Purkinje neurons during associative
learning. Then, in Aim 2 (K99), I will determine how simple spikes in functionally defined groups of PNs influence
behavioral output. These initial studies will allow me to determine, in Aim 3 (R00), how reward-related signals in
complex spike responses shape timing signals in simple spike responses and therefore modulate behavior
during learning. Together, this proposal will define cerebellar computations using non-motor signals and could
profoundly enrich our understanding of cerebellar function. In the K99 phase, I will be mentored by Dr. Karl
Deisseroth, co-mentored by Dr. Liqun Luo, and will be advised by an exceptional advisory team composed of
Dr. Sean Quirin, Dr. Scott Linderman, and Dr. Reza Shadmehr. With their support and the tremendous scientific
environment at Stanford University, I will gain technical training in two-photon holographic stimulation,
extracellular electrophysiology, probabilistic modeling, and conceptual training in cerebellar neuroscience. This
training will prepare me well for my long-term goal of leading my own laboratory, where I will integrate advanced
experimental techniques with computational modeling to understand cerebellar computation.

Public health relevance
Project Narrative Clinical evidence suggests that the cerebellum plays key roles in cognitive and social behaviors, but a circuit- level understanding of how it performs non-motor computations is lacking. The proposed research will apply sophisticated neural recording and control techniques to determine how cerebellar Purkinje neurons contribute to reward learning. This research program will define non-motor computations in the cerebellum, a critical prerequisite to isolating cerebellar disruptions that underlie cognitive impairments in neurological disorders.